Administrative Core

PROJECT SUMMARY
Given the size, complexity, duration, and scope involved, the Administrative Core will be fundamental for
enabling the successful establishment and operation of the entire program. All costs for administrative support
for the Cores and Projects are included here. Dr. Timothy Blackwell will assume ultimate administrative
responsibility for the management of this Core. Administrative and clerical support for the entire program will
be shared by all Project Leaders, Core Leaders and investigators. This Core will provide and maintain all of the
administrative space and functions for the entire program. Administrative functions will include keeping and
monitoring of budgets, maintenance of the personnel database for grant effort, interactions with administrative
offices at Vanderbilt University Medical Center, the Translational Genomics Institute, and the NIH regarding
budgetary and other administrative matters, and scheduling and organizing meetings and presentations. This
Core will coordinate and support the activities of the Internal Advisory Board and the External Scientific
Advisory Board. The basic functions and objectives of the Core include: quality management of program
resources, integration of the program, oversight of deliverables within the assigned timeframe, and leading the
vision. To achieve these objectives, detailed plans are presented for administrative structure and leadership,
advisory boards, managerial responsibilities, review mechanisms, and communication/meetings.

Public health relevance
PROJECT NARRATIVE As per the instructions included in PAR-21-088, this narrative does not need to be completed for this component. Please see Project Narrative for the entire Project in the Overall Component.